E-cadherin deficient epithelium drives airway fibrosis in idiopathic subglottic stenosis

Project Summary
Dr. Alexander Hillel is a faculty member in the Department of Otolaryngology-Head & Neck
Surgery at the Johns Hopkins School of Medicine where his clinical practice is dedicated to the
medical and surgical management of subglottic stenosis. Through the support of a R01
Research Project Grant, he and co-Investigator, Dr. Ramana Sidhaye, seek to better
understand how the dysfunctional epithelial barrier contributes to the spontaneous fibrosis seen
in idiopathic subglottic stenosis (iSGS). iSGS is a rare but life-threatening disease that
exclusively affects healthy, peri-menopausal women. In iSGS, scar forms in the upper airways
narrowing the subglottic larynx, and resulting in shortness of breath and communication
disability. Specifically, the investigator team will focus on E-cadherin, an apico-adherens
junction protein in epithelium, as the cause for barrier dysfunction in iSGS. The deficiency in E-
cadherin creates a permeable barrier allowing for common antigens to pass through the
epithelium and trigger fibrosis. This proposal will study how the loss of E-cadherin in epithelial
cells leads to scar formation in a mouse model and by using human epithelial cells and
fibroblasts isolated from iSGS patient biospecimens. It will also study a novel surgical procedure
that restores the epithelium after excising scar tissue to assess if E-cadherin is the critical
protein involved in preventing scar from reforming. Finally, the proposal will investigate
improving saccharide binding to E-cadherin, through a process called fucosylation, as a novel
therapy to restore E-cadherin and epithelial barrier function. Through a combination of in vitro
and in vivo modeling, participation from patients with iSGS, and assessment of a novel surgical
procedure, the investigator team is uniquely poised to transform our understanding and
treatment of iSGS.

Public health relevance
Project Narrative Idiopathic subglottic stenosis is a rare, life-threatening disease of the upper airways characterized by scar tissue narrowing the subglottis and trachea, which results in shortness of breath and at times airway obstruction. This proposal will investigate how a deficiency in the epithelial barrier protein, E-cadherin, causes epithelial barrier dysfunction and contributes to the development of the scar tissue that forms spontaneously in the subglottis. The proposal will study a novel surgical procedure that restores the epithelium after excising scar tissue to assess if the E-cadherin is the critical protein involved in preventing scar from reforming.